Mbarara University Research Ethics Education Program

PROJECT SUMMARY/ABSTRACT
The Mbarara University Research Ethics Education Program (MUREEP) at Mbarara University of Science
and Technology (MUST) in southwestern Uganda, in collaboration with Case Western University (CWRU),
successfully developed and implemented one of the first ever curricula for a 2-year Masters of Public Health
with a focus on Research Ethics (MPH-RE) program in the Eastern Africa region. With this nationally
accredited curriculum, MUREEP enrolled 23 MPH-RE trainees (15 females and 8 males) who were admitted
to the program, nearly doubling the proposed 12 in our funded proposal. More than 750 participants attended
various non-degree courses for skills development in research and research ethics (the targeted number was
525); and 43 faculty and graduate students attended two workshops on mentoring and capacity development.
The MUREEP Responsible Conduct of Research (RCR) course is highly sought after at MUST and in the
region, registering 425/753 (56.4%) people who completed the course. Despite the national progress in
developing infrastructure for the review of research and the protection of human research participants, Uganda
still has a small number of professionals with in-depth training and expertise to review complex contemporary
research such as emerging health technologies and One Health (OH) research and to teach research ethics.
In this proposed renewal application, we will extend and consolidate the delivery of research ethics education
at MUST and build capacity for 3 neighboring institutions in southwestern Uganda. If funded, we will: 1a)
integrate the teaching of research ethics into the general MPH program and other university initiatives and
components with support from local faculty, including program alumni; (b) develop new content to address
emerging ethical issues 2) scale-up training for students, faculty, members of research ethics committees
(RECs), and other target audiences in southwestern Uganda to enhance capacity related to ethics in research,
genetics, genomics, and emerging health technologies through the establishment of the RCR-Training
Advisory Center and the Research Ethics Café. 3) enlarge the cadre of faculty who can serve as mentors in
research ethics and integrate responsible mentoring into the culture of the Faculty of Medicine at MUST
through the development and implementation of a mentor-the-mentor program. If funded, over the next 5
years, MUREEP will provide in-depth research ethics education to 16 MPH-RE trainees with full scholarships
and other self-funded students, support their practicum at local RECs and at national research regulatory
bodies, in the community, and mentored research projects in research ethics. MUREEP graduates will have
the expertise to lead and serve on RECs, review protocols of research involving emerging technologies, OH
approaches, and during public health emergencies. If funded, we will continue to build and strengthen multi-
level research ethics capacity in SW Uganda by offering non-degree short courses for skills development to
at least 750 participants and an annual workshop on “Bioethics and Human Rights.”

Public health relevance
NARRATIVE This Mbarara University Research Ethics Education Program (MUREEP) being implemented at Mbarara University of Science and Technology (MUST) in southwestern Uganda, in collaboration with Case Western University (CWRU), seeks to extend and consolidate the delivery of research ethics education at MUST and build capacity for 3 neighboring institutions in the region. Over the next five years, MUREEP will develop content for two new special interest courses, “Ethical Issues in genetics/genomics and Emerging Health Technologies and “One Health Research Design and Research Ethics”, and incorporate them into the Master of Public Health with a concentration in Research Ethics curriculum. We will provide in-depth research ethics education to 16 MPH-RE trainees on full MUREEP scholarships and other self-funded students, build and strengthen capacity at MUST and at the neighboring institutions by offering non-degree short course training to 750 participants, scale up training in research ethics through the establishment of the RCR-Training Advisory Centre and a quarterly Research Ethics Café, and enlarge the cadre of faculty who can serve as mentors in research ethics through mentoring the mentor, FREiM (Faculty Reaching Excellence in Mentoring).